Behavioral Science Strategies to Increase Hypertension Diagnosis and Treatment

Project Summary
Elevated blood pressure is a leading risk factor for mortality worldwide, yet much of this mortality is preventable
through early diagnosis and sustained use of available treatments. Low and middle-income countries face a
disproportionate burden of hypertension, as they account for over 80% of people living with hypertension.
Increasing the diagnosis, treatment, and control of hypertension is therefore essential for improving health
outcomes. In the world's largest country, India, hypertension prevalence among adults remains high and a vast
majority of those with hypertension are undiagnosed or not receiving care. Although some Indian states have
launched home-based screening programs in which health workers perform blood pressure measurements,
linkage to care has been low among high-risk individuals. Barriers to clinic-based confirmatory blood pressure
measurement and subsequent linkage to care include incorrect beliefs about the need for treatment as well as
costs and inconveniences associated with care-seeking. This project will utilize insights from behavioral
science to address important barriers to clinic-based confirmatory blood pressure measurement and linkage to
hypertension care. The project will test behavioral strategies that help individuals form correct beliefs about the
need for treatment and that offset the costs associated with care-seeking. Building on our expertise in
behavioral science research and our extensive prior work in India, the BETTER HEART study (Behavioral
Science Strategies to Increase Hypertension Diagnosis and Treatment) will use a randomized controlled trial
with a factorial design to determine the effectiveness of two promising and scalable behavioral science
strategies to increase uptake of clinic-based hypertension care in a large Indian state. Based on strong
engagement with key stakeholders, the study will have these specific aims:
Aim 1: Adapt
pressure
and refine promising user-centered strategies for promoting clinic-based confirmatory blood
measurement for the Indian context using participatory prototyping and survey experiments.
Aim 2: Determine the effectiveness of enhanced hypertension counseling and financial incentives for
increasing clinic-based confirmatory blood pressure measurement.
Aim 3: Conduct a qualitative evaluation to contextualize the effectiveness data and inform future
implementation of strategies on a larger scale.
Findings from this study will (a) strengthen our understanding of how to adapt behavioral science strategies to
local settings and (b) advance the scientific evidence on behavioral strategies to address the growing burden
of hypertension in India and other LMICs.

Public health relevance
Project Narrative Elevated blood pressure is a leading risk factor for mortality worldwide, yet much of this mortality is preventable through early diagnosis and sustained use of widely available treatments. In India and many other low- and middle-income countries, there is a vital need for scalable interventions that can increase hypertension diagnoses among people with elevated blood pressure, as this is the biggest gap that impedes hypertension treatment and control. This project will adapt and test several inexpensive behavioral interventions to increase diagnosis and treatment for hypertension in India.